Cardiovascular Health Effects Innovation Research Program

The CV HEI Program aims to build a capability that currently does not exist in an area of public health that represents the most significant cause of morbidity and mortality in the world. Accordingly, our program fills an important gap in DNTPs portfolio of models, assays, and assessment approaches. It will provide unique insights into environmental contributions to a significant public health burden and broaden DNTPs approach to identifying human-relevant environmental health hazards. Building this pipeline de novo and aligning it to our fundamental understanding of CV pathobiology should strengthen our ability to experientially build confidence in the predictivity of mechanistic bioactivity screens. Building an innovative disease-screening paradigm will substantially enhance our ability to link environmental exposures to important and contemporary diseases.

The CV HEI Program intends to engage the full breadth of the DNTP mission and goals. CV disease is clearly a contemporary public health challenge. The programs path toward capability development will enable evidence-based approachesbeginning with in silico QSAR modeling and medium- to high-throughput bioactivity screening and continuing through complex in vitro confirmatory assays and holistic in vivo assessment in animal models enhanced for assessment of fundamental physiologic measures. Early predictions informed by in silico models and in vitro bioactivity will be qualified in progressively complex assay systems allowing us to build confidence in early pipeline steps, assess model applicability domain, and identify capability development needs. The assay systems used will be aligned to known human CV failure modes and reflect human biology as much as the complexity of the system permits with a goal of optimizing the translational relevance of the outcomes. We will define a novel paradigm for environmental hazard assessment working collaboratively with government, academic, and industry colleagues. Postdoctoral trainees will contribute to key projects. The CV HEI Program will define and test a full pipeline of capabilities. The outcomes of our efforts will be communicated in the varied channels available to us, including usual scientific communications (abstracts, presentations, peer-reviewed manuscripts), National Institute of Environmental Health Sciences media platforms and, when appropriate, NTP-branded publications.